Molecular Characterizations of the Pathophysiology of Type 2 Diabetes in Hispanic/Latino Populations

ABSTRACT
Type 2 diabetes (T2D) is a common multifactorial metabolic condition characterized by persistently
elevated blood glucose concentration. T2D is a major driver of global health burdens, with a disproportionate
impact on historically marginalized populations, specifically, US Hispanic or Latino (HL) populations. HL
populations have an increased prevalence of T2D compared to non-Hispanic whites; however, they are often
underrepresented in genetic studies and have strikingly limited representation in multi-omic studies. The current
work proposes to use deeply phenotyped cohorts in conjunction with multi-omic data at multiple timepoints to
better understand the biological mechanisms contributing to T2D. Aim 1 will identify molecular markers
associated with T2D cross-sectionally by leveraging transcriptomics, proteomics, and metabolomics data in
multiple cohorts. We will perform differential abundance analyses in the available omic platforms from Mexican
American participants in the Cameron County Hispanic Cohort (CCHC) and the Hispanic Community Health
Study/Study of Latinos (HCHS/SOL) using linear regression. We will assess replication and generalizability of
significant markers from each omics platform by analyzing Mexican American and non-Mexican American
holdout sets from the CCHC and the HCHS/SOL. To explore molecular profiles associated with disease onset,
Aim 2 will utilize longitudinal data across available omics to pinpoint signals associated with incident
T2D. Using multiple time points collected from Mexican American participants in the CCHC and HCHS/SOL, we
will perform multiple linear mixed model analyses. We will assess replication and generalizability of significant
markers from the transcriptomics and metabolomics results in holdout sets from the CCHC and HCHS/SOL, as
in Aim 1. Aim 3 will identify likely functional mechanisms underlying T2D risk and associated causal
relationships. We will utilize ancestry-informed colocalization, Mendelian randomization, and phenome-wide
association studies, to better characterize biological processes involved in T2D in HL individuals by leveraging
electronic health record data available from BioVU and AllofUS. These analyses will explore causal and
functional evidence for molecular features identified in Aims 1 and 2, our preliminary data, and the literature. We
anticipate that results from Aim 3 will illuminate specific biological mechanisms contributing to risk and
progression of T2D via genetic mechanisms. Together, these aims will characterize molecular factors associated
with T2D and development in HL populations, enhancing our understanding of cellular changes associated with
T2D in blood, and potentially illuminating clinical and therapeutic targets for future research.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes (T2D) affects over 35 million adults in the United States, with Hispanic/Latino populations experiencing disproportionate prevalence and complications. This study aims to advance understanding of T2D in these populations by leveraging multi-omic data (transcriptomics, proteomics, and metabolomics) from two large and extensively phenotyped cohorts to identify key biomarkers associated with T2D risk and pathogenesis. By uncovering causal molecular pathways and biomarkers, this research will provide a critical foundation for discovering novel insights to advance precision medicine and therapeutic interventions.